Administrative Supplement for the MARC U*STAR Training Program at the University of Rhode Island: Graduate Student Inclusive Mentoring Training

PROJECT SUMMARY/ABSTRACT
The following is an Administrative Supplement application for Curriculum or Training Modules to Enhance
Undergraduate Biomedical Research Training (NOT-GM-22-014) for award number T34GM131948 MARC
U*STAR Training Program at the University of Rhode Island.
In this administrative supplement application, we describe the design and implementation of a new inclusive
graduate student mentoring training program at the University of Rhode Island. This program will promote
more effective mentoring in the biological and biomedical sciences through the development of evidence-
informed educational and training modules and activities.
Specifically, we are requesting funds to send four additional URI faculty and staff from the College of the
Environment and Life Sciences (CELS) to the Entering Mentoring Facilitator Training, hosted by the Center for
the Improvement of Mentored Experiences in Science (CIMER) at the University of Wisconsin-
Madison. Facilitating Entering Mentoring is a two-day “train-the-trainer” workshop designed to increase the
capacity for research mentor trainings offered at colleges and universities, research institutes, and
governmental organizations.
Following completion of NRMN Mentoring Facilitator Training, MARC team members will design and develop a
3-4 module graduate student inclusive mentoring training program that allow participants to delve more deeply
into the various components of inclusive mentoring practices and roles as graduate mentors in research
environments. The objectives of these modules will be to: (1) Cultivate awareness among graduate mentors
on the need for inclusive approaches; (2) Provide strategies for cultivating sustained dialogue between
graduate mentors and undergraduate mentees; and (3) Support graduate research mentors in the
development of their own inclusive mentoring.

Public health relevance
NARRATIVE The following is an Administrative Supplement application for award number T34GM131948 MARC U*STAR Training Program at the University of Rhode Island. We are proposing the design and implementation of a new inclusive graduate student mentoring training program at the University of Rhode Island. This program will promote more effective mentoring in the biological and biomedical sciences through the development of evidence-informed educational and training modules and activities.